Role of VE-PTP in Restoration of Lung Vascular Endothelial Junction Barrier and Fluid

Project Summary Lung vascular endothelial barrier function is regulated primarily by adherens junctions (AJs) consisting of VE- cadherin, which mediates adhesion of endothelial cells through homotypic interaction, and associated catenins. Recently, another VE-cadherin partner Vascular Endothelial Protein Tyrosine Phosphatase, VE-PTP, has been identified in regulating endothelial barrier function. Disassembly of AJs through internalization and subsequent degradation of VE-cadherin disrupts the endothelial barrier resulting severe intractable protein-rich pulmonary edema, the central pathogenic feature of ARDS. Restoration of the endothelial barrier is essential for resolving edema, yet the mechanisms underlying re-assembly of AJs are poorly understood. Based on our Supporting Data, in Project 1 we posit that VE-PTP is a central regulator of re-assembly of AJs that plays a critical role in restoring endothelial barrier function through its ability to stabilize VE-cadherin at AJs. We also showed that signaling via Hypoxia-Inducible Factors (HIFs) was required for the synthesis of VE-PTP. Notably, in addition to VE-PTP binding to VE-cadherin, another pool of VE-PTP is associated with Tie2, the tyrosine kinase receptor present in the endothelial plasmalemma, and which functions to restrain Tie2 activity. On the basis of these observations, in Project 1 we will pursue the following Specific Aims: (i) we will determine the synergistic role of (a) HIF-dependent expression of VE-PTP as an adaptive mechanism promoting the stabilization of VE-cadherin at AJs, and (b) HIF-dependent activation of Rac1 and Cdc42 at AJs in sealing and strengthening the AJ barrier and thus restoring lung fluid balance; (ii) we will determine the role of VE-PTP interaction with Tie2 in regulating the repair of AJs through the activation of Tie2 signaling and the translocation of VE-PTP to VE-cadherin, and resulting in VE-cadherin stabilization; and (iii) we will determine the therapeutic value of (a) blocking prolyl hydroxylases (PHDs) to activate HIF-mediated transcription of VE-PTP, and (b) inhibiting Tie2 interaction with VE-PTP in restoring lung vascular barrier function and fluid balance in models of inflammatory lung injury. We will apply a rigorous multidisciplinary approach to define the signaling mechanisms activated by VE-PTP interaction with VE-cadherin in restoring the integrity of lung endothelial barrier, with the intent of identifying new targets to normalize lung fluid balance and the course of inflammatory lung injury.

Public health relevance
Narrative VE-PTP interaction with VE-cadherin at adherens junctions (AJs) of the endothelium is required for AJs re- annealing. We will study the function of VE-PTP that may have an essential role in the restoration of lung endothelial junctional barrier and fluid balance after inflammatory injury.